From Neural Control of Movement to Treatments for Spinal Cord Injury

Project Summary/Abstract
Over the last 15 years, our NINDS-funded research has focused on understanding transmission in descending
motor pathways and spinal cord networks during motor behaviors in humans with and without spinal cord injury
(SCI), with the long-term goal of maximizing the activity of spared pathway connections to enhance recovery
potential. Our studies revealed that in people with SCI, corticospinal and reticulospinal systems contribute
differentially to muscle weakness and functionally relevant behaviors, such as fine and gross grasping
manipulations, compared with control subjects. Imbalanced contributions from these descending motor systems
were found when spasticity and muscle spasms were present, providing light for the mechanisms of hyperreflexia
following SCI. Motoneuron responsiveness to corticospinal, reticulospinal, and afferent input decreased in a task-
dependent manner. Our research group pioneered the use of spike-timing dependent plasticity in the
corticospinal pathway, from basic proof-of-principle studies on Hebbian plasticity to randomized placebo
controlled clinical trials showing that plasticity at corticospinal-motoneuronal synapses improves exercise-
mediated recovery after chronic incomplete SCI.
In this application, we request to consolidate two ongoing NINDS-funded proposals that focus on the control of
voluntary movement (R01NS090622) and spasticity and muscle spasms (R01NS100810). We will leverage our
existing knowledge to produce new research that challenges the existing paradigm by integrating information
across residual networks in the subacute and chronic phases of SCI and focuses on understanding: a)
transmission in a widespread set of spared descending motor pathways and spinal circuits, b) hyperreflexia in
these spared systems, and c) neuroplasticity-based therapies. Our research protocol will build on our past
successes using cutting-edge neurophysiological, neuroimaging, and behavioral tools. We will employ more
advanced spinal cord imaging methodologies, high-density surface electromyography recordings, and new
physiological examinations using multidimensional behavioral tools to enhance our understanding of residual
connections in humans with subacute and chronic SCI. Successful completion of this research will increase our
understanding of the neural control of movement and symptoms, including spasticity and muscle spasms, in
other neurological disorders (i.e., stroke, multiple sclerosis, and ALS). This research also may provide new
avenues for treatments and assessment of humans with SCI and other neurological disorders.

Public health relevance
PROJECT NARRATIVE Despite improved survival rates and treatment options, individuals with spinal cord injury (SCI) continue to face lifelong disability. Due to disruptions that occur in the pathways of the central nervous system, people with SCI often experience significantly reduced ability to control their movements as well as painful muscle conditions such as spasticity, reducing independence, placing increased burden on caregivers, and increasing healthcare expenses. This project is relevant to public health because it will help guide our understanding of how remaining neural connections reorganize after injury and how transmission in these motor pathways may contribute to the development of overactive reflexes, providing comprehensive knowledge about how to improve existing treatments and develop new rehabilitation strategies for SCI and other neurological conditions.